Sensory Augmentation, Restoration, and Modulation Using a Spinal Neuroprosthesis

Project Summary
The physical world contains signals encompassing the entire electromagnetic spectrum, and yet human
perception of the world is limited to our five senses. To augment our senses, it is essential to first develop
methods that can effectively transmit high-bandwidth information to the brain. Researchers working on brain-
machine interfaces have successfully extracted movement signals from the brain to control external devices.
Yet, methods that augment, restore, or modulate sensory perception are currently limited. Lack of real-time
sensory feedback from a brain-machine interface or neuroprosthetic device prevents optimal motor control and
thus limits sensorimotor rehabilitation. Loss of sensation due to life-altering injuries and disorders affects the
quality of life of millions of Americans. Thus, methods that mimic sensory signals and interface them directly with
the brain are an unmet clinical need. This project proposes a novel spinal sensory neuroprosthetic interface
using sensory spinal cord stimulation (SSCS) with the ability to augment, restore, and modulate sensory
perceptions. This radically innovative approach has the potential to impact a wide array of neurological conditions
by addressing sensory restoration and allows for the exploration of the limits of human sensory perception. Pre-
clinical experiments in rodents and rhesus monkeys demonstrated that animals learn to detect and discriminate
artificial sensations induced by SSCS. To achieve clinical translation of SSCS technology, this proposal involves
a feasibility study, conducted in patients undergoing spinal cord stimulator implantation for the treatment of
chronic pain. First, the relationship between SSCS-induced sensory perceptual thresholds, just-noticeable
differences, and stimulation parameters will be established (Goal 1). Second, human subjects will be trained to
detect and discriminate variations in signal intensity and orientation of non-native signals such as infrared, UV
light, magnetic fields, etc. using SSCS-induced perceptual sense, and ultimately subjects will learn to use these
novel perceptual abilities to navigate a spatial environment with non-native signal cues (Goal 2). Third, lower
limb amputee subjects will learn to intuitively perceive movement and location of their prosthetic limbs during
locomotion via real-time closed loop sensory feedback using SSCS (Goal 3). This project is innovative because
it uses FDA-approved technology (spinal cord stimulation) in a new context, all without changing the patient’s
standard-of-care. The ability to augment, restore, and modulate perceptions will be an unprecedented
development in the field of sensory neuroprosthetics. Successful execution of proposed goals will not only launch
a new line of augmentation research, but it will also showcase that SSCS can be widely applicable in the
rehabilitation of patients suffering from sensory deficits due to neurological disorders and injuries.

Public health relevance
Project Narrative Neuroprosthetic technologies that can restore sensory perception in individuals with sensory deficits caused by an injury or disorder are still in their infancy, while technologies that augment perception of signals outside our perceptual world do not yet exist. This proposal aims to test a novel neuroprosthetic technology, sensory spinal cord stimulation (SSCS), for the augmentation, restoration, and modulation of sensory perceptions in human subjects undergoing spinal cord stimulator implantation. Successful implementation of proposed goals will launch an innovative line of sensory augmentation research and will accelerate the development of novel methods to treat sensory deficits caused by stroke, traumatic brain injuries, limb amputations, and spinal cord injuries.